The Vira Platform: A Contextually Triggered Just-in-Time Adaptive Intervention for Opioid Use Disorder

ABSTRACT
Although buprenorphine is a first-line intervention for Opioid Use Disorder (OUD), maintaining adherence to and
retention in treatment is a significant challenge. A substantial portion of patients receiving buprenorphine
discontinue treatment prematurely and/or return to illicit opioid use placing them at increased risk for overdose
and death. Converging lines of evidence implicate negative affect, sleep deficiency and anhedonia as important
risk factors that are associated with increased drug craving and a reoccurrence of opioid use. In turn, greater
craving, and subsequent opioid use, are posited to be mechanisms underlying buprenorphine discontinuation.
There is a critical need to develop innovative, scalable, solutions that modify and address these risk factors to
support retention in live saving medications such as buprenorphine. The Vira Healthcare Platform is a digitally
enhanced behavior change technology that has primarily been used in the management of mental health
symptoms. It consists of a patient smartphone application that utilizes mobile sensing to garner insight about
patterns of behavior as well as provide tailored just-in-time interventions to support behavior change. It is
accompanied by an associated practitioner portal which allows clinicians or coaches to schedule customized
notifications with skills, tips, and tools to support patients. The platform utilizes well-established principles from
evidence-based therapy (Behavioral Activation) to provide users with the insights to sustain wellbeing and better
manage opioid-related risk factors. The overarching objective of this proposal is to modify and extend the Vira
Platform, augmented by coaching support from certified peer recovery support specialists (PRSS), to improve
patient outcomes for OUD by delivering a digital therapeutic that integrates sensors to provide just-in-time
interventions to address risk factors associated with poor treatment response – negative affect, sleep deficiency,
and anhedonia. Specifically, this proposal seeks to obtain FDA authorization for the Vira Platform as a
prescription digital therapeutic intended to extend the efficacy of buprenorphine. The study will be accomplished
through two primary aims: (1) UG3 - using a user-centered design, adapt and refine the Vira Platform to increase
relevance and usability for individuals with OUD and conduct a pilot feasibility trial; and (2) UH3 – conduct a
pragmatic 2-arm randomized clinical trial among 340 patients with OUD, engaged in outpatient buprenorphine
care, to evaluate the effectiveness of the Vira Platform plus treatment-as-usual (TAU), relative to TAU alone, in
terms of retention in buprenorphine (primary endpoint), engagement in substance use treatment (secondary
endpoint), and opioid use, craving, negative affect, sleep, anhedonia, wellbeing / quality of life, and incidence of
adverse events (secondary outcomes). Go/No-Go criteria to advance from the UG3 to UH3 phase include: a)
complete feasibility trial by successfully enrolling proposed sample size and b) file Q-submission/receive FDA
feedback. If successful, this study will demonstrate the efficacy and safety of a simple, scalable, intervention that
may easily augment standard OUD care through a prescription digital therapeutic.

Public health relevance
PROJECT NARRATIVE Many patients stop medication-based treatments for Opioid Use Disorder (OUD) prematurely, placing them at increased risk for overdose and death. Providing targeted interventions for OUD, particularly through an accessible, digital health platform, is a potential way to enhance recovery and keep patients engaged in care. The current study seeks to test whether a digital mental health platform, delivered by peer recovery support specialists to individuals prescribed buprenorphine medication, will improve treatment outcomes for this high- risk population.